Conformational mechanisms of mGluR gating and regulation

SUMMARY/ABSTRACT
G-protein–coupled receptors (GPCRs), the largest class of membrane signaling proteins, respond to a wide
array of extracellular stimuli to initiate intracellular signaling via G proteins and arrestins. Recent studies have
provided snapshots of GPCR structures in distinct conformations and revealed that they are extremely
dynamic. The conformational dynamics appear to be central to ligand recognition, activation and signaling.
Membrane receptors have evolved to respond to precise spatio-temporal concentration profiles of extracellular
ligands. In the nervous system, neurotransmitter receptors encounter a wide range of neurotransmitter
concentrations and spatio-temporal profiles. Key factors are the small extracellular volume of the synaptic cleft,
pumps and/or enzymes that remove neurotransmitter, and diffusion. Additionally, neurotransmitter receptors
can be localized within the synapse both pre- and postsynaptically, as well as extrasynaptically where they can
encounter neurotransmitter released either locally, which briefly reaches low millimolar levels within the cleft,
and spillover from nearby synapses, which reaches lower concentrations. Metabotropic glutamate receptors
(mGluRs) are found pre- and postsynaptically at excitatory glutamatergic synapses, as well as on glia and at
inhibitory GABAergic presynaptic nerve terminals, meaning that they are activated by both high local
concentrations near the site of release and spillover. mGluRs of various kinds can be found together in
presynaptic nerve terminals, even when they are all coupled to the same G protein. And they can dimerize,
generating hybrid or in some cases totally unique properties and pharmacological profiles. To understand what
each mGluR subtype does and develop effective drugs to treat the neurological disorders in which they are
implicated, we need to understand how they function and how they are regulated. Our goal here is to define
the molecular mechanisms that set and regulate the functional properties of homo- and heteromeric mGluRs at
synapses and put into place assays that can be used to screen modulation in the nervous system.

Public health relevance
NARRATIVE G-protein–coupled receptors (GPCRs), the largest class of membrane signaling proteins, represent one of the broadest class of drug targets. The GPCRs that respond to glutamate, the main excitatory neurotransmitter of the brain, the mGluRs, have been implicated in various neurological disorders and identified as potential drug targets. We propose to study the molecular mechanisms that set and regulate their function at synapses and that can be used in drug assays in the nervous system.